Mechanisms of protein degradation that control signal transduction by Ras-Raf-MEK-ERK

Project Summary
This proposal aims to discover mechanistic insights into how signal transduction by the highly
conserved Ras-Raf-MEK-ERK pathway is modulated by regulated protein degradation. In humans, mutation
of the gene BRAF, encoding one of three human Rafs, is a driver event in the development of malignant
melanoma. Indeed, the mutation BRAF(V600E) confers constitutive kinase activation and is one of the most
frequent mutations found in this cancer. Melanoma growth can be suppressed by inhibition of Raf kinase
activity. However, development of drug resistance and disease relapse occurs frequently, indicating that truly
effective treatments will require additional drug strategies. Our work, utilizing Caenorhabditis elegans as a
simple model to investigate signal transduction by this conserved pathway, demonstrates that C. elegans Raf
signaling is kept in check by inhibitory mechanisms that include phosphorylation and protein degradation (de
la Cova and Greenwald, 2012). For this proposed research, we use the C. elegans model to design and begin
an RNAi screen to identify conserved kinases and phosphatases that regulate Raf. We find that CDK2 is
necessary for Raf protein degradation, and that loss of CDK2 enhances phenotypes caused by a mutant,
activated Raf engineered to carry the same mutation as BRAF(V600E). Our long-term goal is to identify new
molecular targets for the development of drugs capable of inhibiting Raf signaling. Toward this goal, our
overall objectives in this application are to (i) identify additional kinases and phosphatases that impact Raf
protein degradation and their requirement for regulating BRAF in human cells, and (ii) determine the
mechanism and consequences of Raf regulation by the kinase CDK2. Our central hypothesis is that
conserved mechanisms, such as phosphorylation of the Raf protein, act to prevent aberrant Raf activation.
The rationale for this project is that our discovery of inhibitory control mechanisms governing signal
transduction by the Ras-Raf-MEK-ERK pathway will inform new strategies of drug therapy for melanoma.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will address a critical gap in our understanding of how aberrant signal transduction by the Ras-Raf-MEK-ERK pathway leads to cancer. Specifically, these discoveries will provide insights into cellular mechanisms that suppress tumor development in the presence of the common, melanoma-associated BRAF(V600E) mutation, and potentially lead to novel therapeutic strategies. Thus, the proposed research is particularly relevant to the NCI mission to support cancer research that advances scientific knowledge and helps people live longer, healthier lives.